Central Mechanisms Regulating Macronutrient Intake

Obesity and diabetes are major public health issues that affect quality of life and also have high social and
economic costs. According to the CDC, approximately 10% of U.S. adults have diabetes now and 33% are
expected to have diabetes by 2050. At the same time, obesity has reached epidemic proportions, with over 60%
of the U.S. population being overweight or obese. Therefore, there is a serious demand for the development of
new therapeutics to combat obesity and diabetes. Fibroblast growth factor 21 (FGF21) is an endocrine hormone
that ameliorates metabolic dysfunction in a number of obese animal models and humans. Extended
administration of FGF21 causes weight loss in rodents, and administration of FGF21 analogs to obese humans
increases weight loss and improves metabolic profiles. Recently, we discovered that FGF21 functions
physiologically and pharmacologically to suppress carbohydrate intake and sweet taste preference. Importantly,
we and others have found that many of the beneficial effects of FGF21 are mediated through its actions on the
central nervous system. However, the mechanism of FGF21 action in the brain and the neuronal target(s) for
these effects has not been determined. The overall goal of this proposal is to identify the neural circuit(s)
regulating FGF21-mediated suppression of carbohydrate intake. The aims of this grant are to 1) determine the
contribution of KLB+ glutamatergic neurons in the nucleus of the solitary tract (NTS) to regulate sugar intake and
sweet taste preference, 2) determine whether KLB+ NTS glutamatergic neurons are glucose sensitive and how
FGF21 modulates their activity, and 3) determine the independent and coordinated effect of FGF21 signaling in
the ventromedial hypothalamus (VMH) and NTS to regulate sugar intake and sweet taste preference. To
accomplish these aims, we have generated novel animal models and tools to examine these experimental aims.
These studies will provide new fundamental insights into the regulation of whole-body glucose homeostasis and
food-related reward by peripheral endocrine signals acting on the central nervous system. In addition, these
studies may identify novel therapeutic targets for the treatment of diabetes and obesity.

Public health relevance
Approximately 78% of Veterans are overweight or obese, which costs millions of dollars in medical and non- medical costs. While treatment of obesity is consistent with the priorities of the VA through personalized, proactive Veteran-driven care, patient compliance has proven inefficient in maintaining long-term weight loss. The central mechanisms regulating macronutrient intake are poorly defined. Our published and preliminary data support the hypothesis that FGF21 acts on the central nervous system to suppress simple sugar intake and regulate sweet taste preference. The proposed research is directly relevant to VA healthcare because of the high disease burden and enormous health care cost that obesity and diabetes is causing in veterans.